Engineering Mesenchymal Stromal Cells to treat Muscle Fibrosis

Project Summary
Mesenchymal stromal cells (MSCs) have been tested in nearly one thousand clinical trials, mostly because of
their ability to secrete factors that can modify host environments. For instance, MSCs can adapt to their niches
and remodel the extracellular matrix. While this property of MSCs can potentially be beneficial to treat fibrosis
and promote tissue regeneration, leveraging this property has been challenging because specific signals that
enable MSCs to remodel the matrix remain to be defined and leveraged in MSC-based therapeutics. Here, we
describe a highly efficient approach to encapsulate individual cells in engineered gel coatings with specifically
defined biophysical and biochemical cues. We have developed this approach to show that soft, thin gel coating
is an enabling cue that increases the production of soluble interstitial collagenases in response to tumor
necrosis factor-α (TNFα). Importantly, our preliminary data show that gel-coated MSCs decrease collagen
deposition in a murine muscular dystrophy model. In this K99/R00 proposal, I will build upon these results to
test the hypothesis that programming of MSCs using specifically engineered microgels activates the potential
of MSCs to inhibit muscle fibrosis. In Aim 1, we will determine the role of engineered gel coating in TNFα-
induced activation of MSCs to produce high levels of interstitial collagenases and degrade collagen, and
understand mechanisms behind this process. In Aim 2, we will investigate the role of gel-coated MSCs in
inhibiting muscle fibrosis and restoring muscle functions. Success of this proposal will lead to an effective
strategy to treat muscle fibrosis, which is a major unmet clinical need. During the K99 phase, I will work with
my advisory committee to enhance my knowledge in biomaterial design, cellular mechanobiology,
pathophysiology of fibrosis, as well as advanced microtechnologies, imaging, and computational approaches to
effectively drive this research project. These experiences together with career development activities described
in this proposal will ensure my smooth transition to an independent investigator at the interface between
mechanobiology and bioengineering to develop novel therapeutic strategies for muscle disorders.

Public health relevance
Project Narrative/Public Health Relevance Statement Muscle fibrosis affects many patients due to progressive loss of muscle strength and impaired mobility. There is no effective treatment. We will develop therapeutic strategies to treat muscle fibrosis by delivering mesenchymal stromal cells in specifically engineered hydrogel coatings.